Economic Stressors and Opportunities as Influences of Emerging Adult Oral Health

PROJECT SUMMARY/ABSTRACT
Oral diseases are among the most common chronic conditions of humankind; their origins can often be traced
to socioeconomic and behavioral circumstances much earlier in life. Frequently overlooked are key life
transitions when behaviors and circumstances are especially fluid and potentially malleable with appropriately
tailored interventions. Emerging adulthood (the transitional period from adolescence to adulthood) is one such
life stage that has garnered limited attention in oral health research. Emerging adulthood is a particularly
sensitive period marked by changes in socioeconomic stressors, health risk factors, and potential protective
opportunities as young people enter new social circumstances. This proposed project combines detailed
measures of economic, social, and behavioral factors with quality assessments of oral and systemic health in a
diverse, prospective emerging adult cohort. We will examine potential interactions by race/ethnicity and gender
identities and the specific behavioral pathways connecting socioeconomic factors to disease risk, potentially
revealing health promotion opportunities during this formative developmental period. Indeed, such insight
informs a long-term objective to test how acquired access to socioeconomic opportunity afforded by higher
education impacts the trajectory of oral diseases, especially among those from minoritized and/or
disadvantaged backgrounds.
This time-sensitive proposal leverages the now-launching NHLBI-supported Economic and Educational
Contributions to Emerging Adults' Cardiometabolic Health (“3E”) cohort study of 4,000 diverse first-year college
students from two public Hispanic-Serving Institutions of higher education (>50% first-generation college
students, >40% Pell Grant recipients). This proposal augments rich prospective economic and behavioral data
with oral health-specific risk factors and self-reported and objective measures oral health. Specifically, this
project will: Aim 1. Examine the influences of early adulthood socioeconomic stressors on oral health over
time, including as potentially modified by race/ethnicity and gender. Aim 2. Examine the contributions of
education-related opportunities (e.g., academic engagement programming, basic needs supports, social
capital) as protective factors against adverse oral health outcomes (e.g., service non-utilization, gingival
inflammation). Aim 3. Assess the mechanistic role of health-related behaviors in linking socioeconomic
stressors and education-related opportunities to oral health outcomes.
Emerging adulthood, a transition period in health behaviors and socioeconomic opportunity, is a potential pivot
point in the development of chronic diseases and health inequality. Understanding influences of oral diseases
near their emergence will inform more effective oral disease prevention efforts.

Public health relevance
PROJECT NARRATIVE While oral diseases are extremely common and can meaningfully reduce quality of life, relatively few studies have examined the causes of oral diseases during young adulthood, a time when many individuals experience a transition in their economic and social circumstances that can lead to changes in their behaviors and their risk of disease. This study will collect detailed information about economic status, social environments, and health behaviors, as well as general health and oral health, among a diverse population of college students, many of whom are from disadvantaged backgrounds. Such information will increase our understanding of the early stages of long-term oral diseases, including diseases that can lead to future problems like tooth loss, in order to help develop programs and policies that can eventually improve oral health for everyone.